Neurodevelopmental effects of flame retardant exposure

Project Summary
Rates of neurodevelopmental disorders (NDDs) with socioemotional deficits are rapidly rising, including general
and social anxiety disorders (ADs, more common in women). Although environmental factors, including chemical
exposures in early development, are universally thought to increase NDD risk, most work to date has almost
exclusively focused on genetic factors. One of the few environmental factors implicated in sex-specifically
impacting behaviors relevant to NDDs with socioemotional deficits is developmental exposure to flame retardants
(FRs). FRs and its components are widely used in electronics, infant products, and furniture, resulting in
ubiquitous human exposure. Our previous work has shown that developmental exposure to the chemical FR
mixture Firemaster 550 (FM 550) sex-specifically alters anxiety and social behavior in several species. Since it
is challenging to directly link environmental chemical exposure to NDD-relevant behavioral and neural endpoints
due to the lack of human-typical social behaviors in many laboratory rodents, we have employed the more
human-relevant, spontaneously prosocial animal model, the prairie vole (Microtus ochrogaster). In the prairie
vole model, developmental FM 550 exposure sex-specifically impacted anxiety, social interaction, exploratory
motivation, and social pair bond formation. The greatest effects were detected in females, who displayed
generalized and social anxiety, while males displayed a decreased ability to form social pair bonds. The
mechanisms by which FM 550 exposure alters the neural systems that are integral to these behaviors and
disorders remain poorly understood, providing the rationale for this proposal. Here we focus on dopamine (DA),
oxytocin (OT) and vasopressin (AVP) systems in the social brain neural network (SBNN), which includes sexually
differentiated brain regions such as the nucleus accumbens (NAcc) that are key for coordinating NDD-relevant
behaviors. We will leverage the prairie vole model and our synergistic expertise in developmental
neurotoxicology, autoradiography, genetics, electrophysiology, and neurochemistry to identify how FM550
impacts DA/OT/AVP receptor expression, receptor action on neuron function, and DA signaling as assessed
using voltammetry in awake behaving animals. Our central hypothesis is that developmental exposure to FM
550 disrupts DA/OT/AVP receptor density, DA/OT/AVP electrical function, and DA signaling in awake, behaving
animals. We address this central hypothesis in voles of both sexes. There are three aims: 1) Test the hypothesis
that developmental FM 550 exposure impacts DA/OT/AVP receptor density and related gene expression, 2) Test
the hypothesis that developmental FM 550 exposure impacts DA/OT/AVP receptor action on neuron electrical
function, and 3) Investigate the effects of developmental FM 550 exposure on DA signaling relevant to social
interactions. Overall, the proposed studies are significant and high impact because they leverage a unique model
animal with enhanced translational value to identify specific novel mechanisms by which DA/OT/AVP receptors,
neuron function and DA signaling are vulnerable to developmental chemical exposures.

Public health relevance
Project Narrative Anthropogenic chemicals are likely contributing to rising rates of neurodevelopmental disorders (NDDs) with socioemotional deficits, but the vast majority of work on NDDs to date has focused on genetic rather than environmental risk factors. Here we employ an animal model of social behavior, the prairie vole, to investigate how developmental exposure to a widespread environmental chemical contaminate impacts areas of the nervous system relevant to two behavioral traits common to many NDDs: anxiety and sociality. To achieve this goal, we focus on a widely-used flame retardant mixture implicated in human and animal studies known to contribute to a wide variety of sex-specific adverse effects on socioemotional related behaviors.